Research Project 1: Vaccine for Rapid Response to Filovirus Outbreak

PROJECT SUMMARY/ABSTRACT – Research Project 1
Ebola virus (EBOV) and Marburg virus (MARV) are filamentous enveloped non-segmented negative sense RNA
viruses representing the two genera that comprise the family Filoviridae. The Marburgvirus genus contains one
species (MARV), while the Ebolavirus genus is comprised of five recognized species: Sudan ebolavirus (SUDV),
Zaire ebolavirus (EBOV), Tai Forest ebolavirus (TAFV), Reston ebolavirus (RESTV), and Bundibugyo ebolavirus
(BDBV). These viruses are important human pathogens with case fatality rates ranging from 70% to 90% for
EBOV, up to 90% for MARV, approximately 55% for SUDV, and 25-50% for BDBV. These agents are classified
as Category A Priority Pathogens by the NIAID/NIH and CDC, and there are presently no licensed active or
passive interventions for exposure resulting from natural outbreak, laboratory accident, or deliberate misuse.
The public health concern is based on both the emerging infectious disease status of these viruses and their
potential use as biologic weapons. An effective prophylactic vaccine would find application with medical
personnel and close contacts during outbreaks in endemic areas of sub-Saharan Africa, with laboratory workers
engaged in filovirus research, and with military and civilian personnel threatened by weaponized filoviruses. The
ideal vaccine to meet both the outbreak and bioweapon scenarios would rapidly confer protection against all
species of EBOV and MARV with a single dose. Among the vaccine strategies tested for single dose protection,
the most successful have been vectored vaccines based on vesicular stomatitis virus (VSV). The progressing
urbanization of sub-Saharan Africa has increased the probability that a filovirus infected individual will enter an
area of high population density either unknowingly or to seek medical aid. As seen in the recent west African
outbreak, the increased mobility within and between the urban centers can rapidly expand the number and
geographic distribution of cases. Thus, in the absence of widespread prophylactic immunization, the most
effective uses of a vaccine against the filoviruses will be protection of healthcare workers and breaking spread
using ‘ring vaccination’. The first application is aided by, and the second application is dependent upon, a rapid
onset of protection. Funded work under NIAID contract HHSN272201700077C supports development of
vaccines for EBOV, SUDV, and MARV that are vectored with rVSVN4CT1, a live attenuated VSV vector that has
proven safe in multiple clinical trials. This application proposes to develop an rVSVN4CT1-vectored BDBV
vaccine through MVS production and IND-enabling toxicology testing, to establish the time to onset of protection
provided by rVSVN4CT1-vectored vaccines against the four filovirus species of greatest concern (EBOV, SUDV,
BDBV, and MARV). In addition, it proposes to address the questions regarding the vaccine valency providing
the most effective formulation for use in a rapid response setting.